Mayo Clinic Hepatobiliary SPORE

OVERALL – PROJECT SUMMARY
The Mayo Clinic Specialized Program of Research Excellence in Hepatobiliary Cancers builds upon four
exceptional and diverse translational projects and three well-constructed and responsive cores that, together,
promise substantial steps forward. In addition, our proposed Career Enhancement Program and
Developmental Research Program are designed with the utmost support. And finally, the Mayo Clinic, the
Mayo Clinic Cancer Center, and the SPORE programs, now underway at the institution, stand behind this
endeavor and will provide important support toward integrating resources, skilled staff, and leadership
guidance to ensure success. This confluence of expertise, resources, structure, and accountability will drive
the initial five years of the HBCs SPORE to achieve its intended goals. Our approach is comprehensive and
milestone-focused.
We look forward to working with NCI leadership, our partners, and our patients to make this program a
success.

Public health relevance
OVERALL – PROJECT NARRATIVE The Mayo Clinic SPORE in Hepatobiliary Cancers (HBCs) aims to develop translational strategies designed to improve early detection, diagnosis and therapeutic treatment for patients facing these fierce malignancies. Each of the four projects will improve scientific knowledge, technical capability, and enhance clinical practice of HBCs medicine by developing and testing interventions that result in improved duration and quality of life for our patients.